Flexible NLP toolkit for automatic curation of outcomes for breast cancer patients

Project summary/Abstract
Breast cancer has the largest number of new cases in world (11.7%). Although the prognosis of
breast cancer patients is generally favorable due to early detection and comprehensive treatment,
20%–30% of patients will still develop distant metastases and cases with progressive stage only
have a median two-year survival time. Breast cancer is widely recognized as a heterogeneous
disease in the sense of both primary tumor metastatic capacity and time to metastatic spread of
disease. High-quality population-based cancer surveillance data are needed to: (1) describe
cancer burden, patterns, and outcomes in order to (2) inform cancer prevention, detection and
control activities; and (3) evaluate interventions on the basis of past and future trends so that
optimal approaches to alleviate burden and suffering from cancer can be adopted. However, the
laborious manual curation process makes the population wise surveillance data collection
challenging. It has been shown in studies that a large percentage of total registry cost is devoted
to labor for data curation, even in the low-income countries. In this project, our mission is to build
a flexible NLP toolset that can be executed locally at the institution level and will curate the clinical
and patient-centered outcomes of breast cancer patients by parsing longitudinally acquired clinic
notes, radiology and pathology reports. In order to test the generalizability of the tools and to
initiate their deployment for data collection, we will partner with both Georgia SEER and California
state cancer registry and will curate the outcome data of past 10-years breast cancer patients
from two institutions across US representing diverse patient populations - Emory University
hospital (Georgia) and Stanford Medical Center (California). We will leverage the previously
developed tools and technologies and extend them to automatically curate the clinical and patient-
centered outcome data – recurrence date and site of recurrence, treatment administered, mental
and physical outcomes – from clinic notes and convert these into structured and query-able
format. The NLP tools will be dockerized and run locally at the hospital registry level for automated
outcome curation. Finally, the NLP extracted outcomes will be shared with State Cancer registry
for evaluation. From a methodological perspective, the framework and the open-source software
tools developed can be employed for cancer research beyond the scope of our project for curating
outcomes regardless of the problem domain.

Public health relevance
Project Narrative While evidence of long-term clinical outcomes and quality-of-life data for cancer patients is trivial for treatment planning, manual extraction of data is an extremely challenging task for human curators and needs hours of manual chart-review. We propose to develop an open-source NLP toolkit for curating treatment administered (chemotherapy, immunotherapy, radiation, surgery) and clinical outcome (progression, recurrence) data longitudinally by parsing varying types of clinical narratives for performing population-wide cancer research. In this study, we will collaborate with two state-wide cancer registries (Georgia and California) for evaluating our NLP developments for cancer data curation and obtain a robust performance evaluation across heterogeneous populations.